Air Pollution, Multidimensional Behavior, and Neuroimaging in Children with Neurodevelopmental Disorders

PROJECT SUMMARY
I am a dually trained neuroscientist and environmental epidemiologist. My primary research interest is the
impact of early life environmental exposures on the developing brain. The goal of this proposal is to gain
training in biostatistics, epidemiology, and data science, supporting my transition into an independent
transdisciplinary researcher in the emerging field of big-data environmental developmental neuroscience. I
propose a novel application of the lagged weighted quantile sum (LWQS) regression to link temporally
resolved air pollution (particulate matter < 2.5 µm; PM2.5) with diagnostic and transdiagnostic (multi-dimensional
behavioral and neural changes) in children with autism spectrum disorder (ASD) and attention deficit
hyperactivity disorder (ADHD). I leverage rich, existent behavioral and magnetic resonance imaging (MRI)
phenotyping from a well-established big-data biobank, the Healthy Brain Network (HBN), along with a novel
spatiotemporal model of weekly PM2.5 exposure. I hypothesize that higher PM2.5 exposure during critical
windows of prenatal development is associated with increased ASD and ADHD diagnosis, and a
transdiagnostic approach captures the population burden of exposure. In the K99 phase, I propose to uncover
mechanistic links between prenatal ambient PM2.5 exposure and behavioral (Aim 1) and MRI (Aim 2)
phenotypes in children with ASD and ADHD. In the R00 phase, I propose to acquire longitudinal behavioral
and MRI data to examine associations between prenatal PM2.5 exposure on developmental trajectories (Aim 3).
To achieve these scientific goals, I will obtain training and mentorship from an expert mentoring team with
transdisciplinary expertise which will provide me with balanced training in both technical skills, and professional
development. Technical skills will cover: 1) high dimensional longitudinal analytic approaches with Dr. Chris
Gennings, 2) environmental developmental epidemiology with Dr. Megan Horton, and 3) processing of big-data
MRI and behavioral datasets with Dr. Mike Milham. Dr. Horton will also lead my professional development
skills training, including grant writing, project management, strategic planning to accomplish short- and long-
term goals, maintaining scientific rigor and reproducibility, and cultivating a professional network. The proposed
complementary training plan positions me to pioneer the use of big data to investigate the link between
multidimensional exposures and behavioral and neuroimaging outcomes in typically and atypically developing
children. My long-term career goal is to use big data to assess the impact of the changing climate on children’s
brain and behavioral outcomes. I will use this K99/R00 as a foundation for a future R01 grant and career as an
independent tenure-track faculty member. This application overcomes barriers in environmental developmental
neuroscience thus advancing our ability to identify mechanisms underlying associations between climate-
related environmental exposures and neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Air pollution (particulate matter < 2.5 um; PM2.5) exposure increases the risk for neurodevelopmental disorders (NDDs), yet the neural mechanisms underlying these associations are largely unknown. This research adopts a transdiagnostic approach to uncover mechanistic links between PM2.5 exposure and behavioral and neuroimaging phenotypes in children with autism spectrum disorder (ASD) and attention deficit hyperactivity disorder (ADHD). Findings will help identify critical windows of susceptibility and underlying mechanisms informing prevention and intervention efforts for these and other NDDs.